DEVELOPMENT OF TECHNOLOGIES THAT ACCELERATE THE IMMUNE RESPONSE TO BIODEFENSE VACCINES

This contract will support preclinical and clinical testing program designed to advance the development of a candidate hemorrhagic fever vaccine using a cross-cutting delivery technology to accelerate protective immune responses. Specifically, the contractor will use the recently developed intradermal electroporation (ID-EP) delivery system with the goal of improving the seroconversion rate. The scope of product development activities that may be addressed through this award span manufacturing and formulation process development through clinical studies, including: manufacturing, characterization and release of pilot lot cGMP material; vaccine stability testing; conduct of non-clinical studies, e.g., Investigational New Drug (IND)-enabling toxicology studies; development, qualification and, where necessary, validation of all assays and reagents needed to support product development.